Interdisciplinary Predoctoral Training in Molecular Biophysics

SUMMARY
This new proposal seeks continuing support for a proven and thriving T32 Molecular Biophysics
Predoctoral Training Program at the University of Colorado, Boulder (CU), currently in its 19th year. The
goal of the Biophysics Training Program is to provide exceptional training to a diverse cohort of promising
trainees, thereby preparing them for leading-edge research careers at the interface of Biology, Chemistry,
Engineering and Physics – or for a broad range of other careers. The 39 training faculty include
internationally recognized established investigators and rising young stars from 5 PhD-granting
departments: Biochemistry, Chemical & Biological Engineering, Chemistry, Molecular, Cellular &
Developmental Biology, and Physics. These faculty and their students use state-of-the-art biophysical
approaches to elucidate fundamental aspects of macromolecular structure, dynamics, mechanism, and
regulation in systems ranging from single molecules to live cells, with direct relevance to human health.
Biophysics is one of the core areas of research on the Boulder campus. Of the 39 training faculty, 22
were hired since the program began, including 10 in the last 5 years. The Biophysics Training Program
has been a key driving force behind this growth. The training program, jointly supported by NIH and CU
Boulder funds, has established a thriving biophysical community with extensive collaborations and large
numbers of joint between biophysicists in different laboratories and departments. Moreover, the program
provides highly robust, innovative training for predoctoral students of biophysics, ensuring they receive a
broad, interdisciplinary foundation needed for current and future success. The newly enhanced training
program combines successful features of the existing program with new elements designed to further
increase program diversity and prepare students to effectively navigate the constantly evolving modern
workforce. Trainees focus on their home PhD program in year 1, then are appointed as Biophysics
trainees in years 2-3 of their graduate studies. Required program elements include core Biophysics
courses and training in Responsible Conduct of Research (RCR) and Rigor and Reproducibility (R&R).
An array of other program activities, many newly added, provide training in critical thinking, self-efficacy,
technical expertise, social proficiency, ethical grounding, sound scientific method, professional skills,
teamwork, and leadership skills. The Biophysics trainees, faculty, courses and other program elements
are regularly assessed to enable timely, effective responses to excellence and challenges as they arise.
Strong outcomes indicate that the program provides highly effective training and support to
Biophysics trainees, as demonstrated by 1) recruitment of high quality students and faculty, 2) increased
participation by underrepresented groups, 3) strong trainee publication, graduation, and career
placement rates, 4) extensive collaborations between training laboratories, and 5) training innovations.

Public health relevance
NARRATIVE The goal of this training program is to prepare exceptional, rigorous and collaborative PhD graduates for productive, science-related careers in Biophysics or other fields. Well-trained biophysicists play essential roles in elucidating the molecular basis of human health and disease. Such researchers investigate the structures, mechanisms, and functions of crucial cellular components, thereby providing the information needed to (i) understand disease on a molecular level and (ii) design new treatments targeting diseases including cancer, diabetes, inflammation, heart disease, immune and neurological disorders.